Investigating aryl hydrocarbon receptor-cofactor interactions that mediate toxicity

? DESCRIPTION (provided by applicant): Exposure to byproducts of industrial combustion, such as dioxins and polycyclic aromatic hydrocarbons (PAH), causes multi-organ phenotypes including cardiotoxicity. Understanding the signaling pathways by which such compounds cause toxicity is crucial for predicting acceptable exposure levels and for reversing the effects of adverse exposure. Dioxins and PAHs activate aryl hydrocarbon receptors (AHR), ligand-dependent transcription factors that recruit cofactors to DNA and directly regulate gene expression. However, our knowledge of AHR cofactor recruitment and regulation is limited. The goal of this application is to identify the transcriptional cofactors by which AHR mediates cardiotoxicity and test the hypothesis that AHR ligands modulate cofactor recruitment. Structurally distinct AHR ligands induce differential transcriptional responses, suggesting that different ligands bind AHR and recruit different cofactors, leading to differential gene expression Consistent with this hypothesis, our preliminary data in zebrafish embryos, an established model of dioxin and PAH toxicity, indicates that AHR-mediated cardiotoxicity is ligand dependent. Acute exposure to the AHR ligand 2, 3, 7, 8-tetrachlorodibenzodioxin (TCDD), but not the AHR ligands 3-methylcholanthrene (3MC) or benzo (a) pyrene (BaP), caused cardiac edema and heart malformation. While the idea of ligand-dependent cofactor recruitment has been established for the estrogen receptor family of transcription factors, whether AHRs act in a similar manner is less well understood. Approximately 20 AHR cofactors have been identified, yet aside from the ARNT protein, it is not known which cofactors are required for cardiotoxicity or whether cofactors are recruited in a ligand-dependent manner. We propose that TCDD-AHR recruits a different complex of transcriptional cofactors than either 3MC-AHR or BaP-AHR and that differential cofactor recruitment underlies ligand-dependent gene expression and cardiotoxicity. In Aim 1 we will identify AHR cofactors required for TCDD-dependent cardiotoxicity. Using genetic approaches, we will test whether candidate cofactors are required for TCDD cardiotoxicity. We will also use unbiased biochemical and proteomic approaches to purify TCDD-AHR from the developing heart and identify interacting proteins. In Aim 2 we will identify ligand-dependent AHR cofactors from whole embryos and select tissues. Using zebrafish `knock-in' strains with epitope tags inserted into endogenous AHR signaling genes, we will test whether known cofactors differentially interact with endogenous AHR depending on the AHR ligand. We will also purify AHR from zebrafish embryos and use mass spectrometry to identify cofactors bound to AHR following exposure to TCDD, 3MC or BaP. Results from this application will identify a mechanism of TCDD cardiotoxicity and will provide a foundation for elucidating how the structure of AHR changes in response to differential ligand binding. Furthermore, our results will increase our understanding of the role of cofactors in endogenous AHR signaling, which may lead to improved treatment for diseases where AHR signaling is abnormal.

Public health relevance
PUBLIC HEALTH RELEVANCE: This application seeks to understand how dioxins, aromatic hydrocarbons and related chemical pollutants cause the heart to develop and function abnormally. Such pollutants cause their toxic effects by activating a protein called the aryl hydrocarbon receptor, and we seek to understand how this protein communicates with other proteins to cause toxic effects in the heart. Our results will improve our ability to predict how exposure to dioxins or related pollutants will affect human health.